The Role of EP300 Mutations in Bladder Cancer Pathogenesis and Drug Response

PROJECT SUMMARY/ABSTRACT
The management of metastatic bladder and upper tract urothelial cancer has been transformed over the past
five years with the FDA approval of anti-PD-1/PD-L1 antibodies, antibody-drug conjugates targeting Nectin-4
and Trop-2, and the fibroblast growth factor receptor (FGFR) inhibitor erdafitinib. Despite these clinical advances,
urothelial cancer remains fatal for most patients with metastatic disease. Nearly all urothelial cancers harbor one
or more mutations in chromatin modifying genes, with mutations in KDM6A, KMT2D, ARID1A, CREBBP, and
EP300 being the most common. The role of mutations in these genes in urothelial cancer pathogenesis remains
poorly understood, as does their impact on systemic therapy response. In preliminary studies, we find that EP300
gene knockout or loss-of-function mutation results in IL-6-JAK1-mediated STAT3 activation and resistance to
erdafitinib. Based on these findings, we hypothesize that EP300 loss-of-function mutations are a mechanism of
erdafitinib resistance in patients with urothelial cancer and that co-targeting IL-6-JAK1-STAT3 signaling could
delay or overcome resistance to FGFR inhibitors. We will pursue three aims to investigate the phenotypic
consequences of EP300 loss-of-function mutations and their role in mediating resistance to erdafitinib in
patients with urothelial cancer. These aims will utilize unique resources assembled by our investigative team,
including: 1) a large prospective cohort of genomically profiled urothelial cancers for which we are collecting
detailed patient demographic and treatment response data, and 2) a large biobank of patient-derived organoid
models of urothelial cancer. In Aim 1, we will study the role of EP300 loss-of-function mutations in mediating
kinase inhibitor resistance using a large panel of patient-derived models, including FGFR3 mutant and wildtype
models. We will also identify mechanism(s) of p300-independent STAT3 activation and the impact of p300-
dependent and independent STAT3 activation on FGFR3 dependence. In Aim 2, we will identify genomic
alterations associated with intrinsic resistance to FGFR3 inhibition using pre-treatment tumors collected from
patients with urothelial cancer, with an initial focus on EP300 co-mutation as a basis for intrinsic resistance to
erdafitinib. Finally, in Aim 3, we will identify mechanisms of acquired erdafitinib resistance using paired pre- and
disease progression tumor and cell-free DNA samples and employ patient-derived models to test combinatorial
strategies designed to overcome or delay erdafitinib resistance. The long-term translational objective of the
studies proposed is to define the mechanism(s) through which EP300 mutations promote urothelial cancer
pathogenesis and the impact of EP300 mutation on systemic therapy response, with the goal of using the
resulting insights to develop mechanistically based combination strategies designed to prevent or delay FGFR3
inhibitor resistance. As EP300 mutations have been identified in other cancer types, the studies outlined in this
proposal will also provide insights into the functional and clinical significance of EP300 mutations in cancer more
broadly.

Public health relevance
PROJECT NARRATIVE Nearly all bladder and upper tract urothelial cancers harbor one or more mutations in chromatin modifying genes, with mutations in KDM6A, KMT2D, ARID1A, CREBBP, and EP300 being the most common. In preliminary studies, we have identified an unexpected link between mutations in the histone acetyltransferase p300, which is encoded by the EP300 gene, STAT3 activation, and sensitivity to the FDA-approved FGFR inhibitor erdafitinib. This project aims to define the mechanism(s) through which loss-of-function EP300 mutations promote urothelial cancer pathogenesis and their impact on systemic therapy response, with the goal of using the resulting insights to develop mechanistically based combination strategies designed to prevent or delay FGFR3 inhibitor resistance.